Leveraging community health workers and a responsive digital health system to improve rates and timeliness of child well visits in the first year of life

ABSTRACT
Timely well visits are essential to ensure the wellbeing of children in their first year of life as they provide
opportunities for delivery of preventive health interventions as well as growth monitoring. Prior studies show high
rates of gaps and delays in the delivery of preventive health interventions, indicative of gaps in well visits, and
reflective of broader health system and community-level barriers. For example, in Tanzania, only 68% of children
receive key recommended preventive health interventions within their first year of life. Utilizing community-based
health workforce capacity and leveraging rapidly evolving digital health innovations hold great potential to
mitigate gaps in service delivery, healthcare access, and caregiver knowledge in this context.
Our multidisciplinary study team recently completed a project that demonstrated the feasibility and efficacy of
mobile phone-based reminders and conditional financial incentives for improving rates and timeliness of routine
preventive health interventions recommended for children. Our team has also shown that using community
health workers (CHWs) is an acceptable approach for addressing caregivers’ knowledge gaps. Building on this
prior work, we propose to develop and evaluate a machine learning approach that allows for the proactive
identification of children who are most likely to experience missed or delayed child well visits. Early identification
could allow for these children to be supported by our integrated, community-based, digital intervention to improve
uptake and timeliness of recommended child well visits. This intervention, called “Huduma Kwa Wakati”,
facilitates timely well visits through a CHW-led outreach and educational intervention that is supported by a
combination of low-cost digital strategies (autonomous mobile phone-based child health protocols, reminders,
clinic operations notifications; conditional incentive offers for adherence to visit schedules). To optimize the
implementation and efficiency of Huduma Kwa Wakati, we propose the following specific aims:
In Aim 1, we will initially collect retrospective data on the characteristics and child well visits of 800 children in
their first year of life. Mothers with children ages 12-23 months will be enrolled from 40 geographic clusters in
the catchment areas of 40 health facilities in four rural districts in Mwanza and Shinyanga regions of Tanzania.
In Year 4, 800 pregnant women in their last trimester of pregnancy will be enrolled into a parallel two-arm clusterrandomized trial. Women will be enrolled from 80 geographic clusters in the catchment areas of the same 40
health facilities. 40 clusters will be randomized into the intervention arm; 40 clusters will be randomized into the
control arm. Women will be followed for up to 15 months, until the child reaches 1 year of age. Child well visit
dates will be documented using government-issued clinic cards. Concurrently, data on all child well visits in each
catchment area since 2019 will be extracted from facility logbooks.
In Aim 2, we will characterize the implementation context for our integrated, community-based intervention to
improve rates and timeliness of child well visits, assess factors associated with its acceptability among mothers
and key stakeholders, develop a training and implementation blueprint, and characterize the cost of the
intervention.
In Aim 3, we will evaluate the feasibility and potential efficacy of a machine learning approach for proactively
identifying children who are most likely to experience missed or delayed child well visits and validate predictive
models using data gathered in aim 1. Child well visits extracted from facility logbooks will serve as training data.
Well visit data collected from the 800 study children will serve as validation data.
Study findings will inform models and interventions to identify children who are most likely to experience missed
or delayed well visits and the relevance and implementation of Huduma Kwa Wakati across a wide range of rural
and low-resource community settings.

Public health relevance
NARRATIVE Many children living in rural and resource-limited settings experience missed or delayed child well visits in their first year of life, leaving them susceptible to illness and undiagnosed developmental delays. The goal of this research is to evaluate whether an integrated community-based digital health intervention can support routine access to recommended child well visits, and whether a machine learning approach can identify children who are most likely to experience missed or delayed visits. The study is conducted in rural Tanzania; however, findings are broadly relevant for identifying children likely to miss recommended visits and for refining digital health strategies that are implemented by nursing or other non-physician cadres of health professionals in community settings.